Interrogating the pathogenesis of COPD using metabolomics and genomics data

Abstract
Chronic lower respiratory diseases, including chronic obstructive pulmonary disease (COPD), are the third
leading cause of death worldwide. While cigarette smoking is a common risk factor for COPD, the risk of disease
also increases with age, and the disease can progress despite smoking cessation. Treatment options for COPD
are limited: existing pharmacologic therapies have at best a modest impact on mortality on a subset of patients.
Thus, a better understanding of the molecular pathophysiology of COPD is needed to guide the development of
new treatments. Large-scale genome-wide association studies (GWAS) of lung function, and COPD have
identified >1,000 independent association signals. Some of these associations are coding and have downstream
targets, such as AGER and SFTPD, that have been implicated as biomarkers and drug targets for COPD by
gene expression and protein data. However, the downstream metabolic implications of these GWAS signals
have been largely unexplored, and substantial evidence links metabolomic signatures to COPD. We are
expanding our previously established PrediXcan method, which was designed for the integration of GWAS with
gene expression loci, to incorporate metabolomics data. This new tool, termed MetaboXcan, will extract more
comprehensive mechanistic information from GWAS and unlock new insights into the pathophysiology of COPD.
By applying a preliminary version of MetaboXcan to the most recent and comprehensive multi-ancestry GWAS
of lung function, we identified metabolic pathways that overlap with strong candidates of interest from our prior
work, including long-chain fatty acid metabolism. In this proposal, we will continue to develop our MetaboXcan
method to incorporate additional metabolomic resources derived from individuals with COPD, as well as disease-
free controls (Aim 1). We will further apply MetaboXcan to achieve enhanced interpretation of large-scale GWAS
for pulmonary disease traits in NHLBI Cohorts (Aim 2) as well as perform validation studies of selected
metabolites (Aim 3). To accomplish these Aims, we have assembled an interdisciplinary collaborative group
representing expertise in statistical genetics, pulmonary epidemiology, integrative genomics, metabolomics, and
pulmonary medicine. Completion of these Aims will establish an expanded view of the metabolomic targets and
pathways influenced by genetic variation for COPD, which will also provide a foundation for future drug
development efforts.

Public health relevance
Project Narrative Chronic lower respiratory diseases, including chronic obstructive pulmonary disease (COPD), are the third leading cause of death worldwide. While cigarette smoking is a common risk factor for COPD, approximately 30% of disease cases occur in non-smokers, underscoring the critical role of genetic risk factors. Treatment options for these diseases are limited: existing pharmacologic therapies have at best a modest impact on mortality on a subset of patients. A better understanding of the molecular pathophysiology of COPD could prompt the development of new treatments. Large scale genome-wide association studies (GWAS) of relevant pulmonary traits have identified >1,000 independent association signals. However, the downstream metabolic implications of these GWAS signals have been largely unexplored. To extract more comprehensive mechanistic information from GWAS and unlock new insights into the pathophysiology of COPD, we will apply novel powerful methods that bring together advances in genomics and metabolomics data for individuals with COPD, as well as disease-free controls.